Function and development of a C. elegans GABAergic interneuron

DESCRIPTION (provided by applicant): GABAergic neurons are a prominent class of neurons whose dysfunction can results in various disease states. The developmental mechanisms that result in terminal differentiation of GABAergic neurons and the functional properties of many GABAergic neurons are incompletely understood. We propose here to use the experimental advantages of the nematode C.elegans to decipher the gene regulatory events - both on the level of cis-regulatory elements and trans-acting factors - that induce the expression of terminal identity markers of a single GABAergic interneuron (Aim #1) and we propose to study a potential role of this GABAergic interneuron in controlling metabolic states and life span of C. elegans (Aim #2). PUBLIC HEALTH RELEVANCE: We propose to study development and function of a single GABAergic interneuron in the nematode C. elegans using a combination of genetic, molecular and physiological approaches.

Public health relevance
Title: Development and function of a GABAergic interneuron PI: Hobert, Oliver PROJECT NARRATIVE We propose to study development and function of a single GABAergic interneuron in the nematode C. elegans using a combination of genetic, molecular and physiological approaches. PHS 398/2590 (Rev. 11/07) Page 1 Continuation Format Page